Catalytic Mechanism, Regulation and Drug-Target Potential of Bacterial Alarmone Hydrolases

Catalytic Mechanism, Regulation and Drug-Target Potential of Alarmone Hydrolases
The research program in our laboratory focuses on understanding bacterial signaling mechanisms through the
molecule (p)ppGpp, a key mediator in bacterial stress responses. Often called the "alarmone," (p)ppGpp helps
bacteria survive adverse conditions such as nutrient starvation and antibiotic exposure. By halting cell growth
and shifting bacteria into a persistent state, (p)ppGpp enables tolerance to chemotherapies without requiring
genetic resistance, contributing to recurring infections. (p)ppGpp level is controlled by both its synthesis and
degradation. The current paradigm of alarmone signaling, however, primarily focuses on the sensory role of
alarmone synthetases, while hydrolases have been largely overlooked. Our goal over the next five years is to
elucidate the catalytic mechanisms and regulatory roles of (p)ppGpp hydrolases. X-ray crystallography will be
used to determine a hydrolase structure bound to a transition-state analog, revealing how the enzyme organizes
its active site for catalysis. Literature and our preliminary data both suggest that alarmone hydrolases may also
sense transition metals like manganese and iron. During infections, host defenses cause metal starvation or
expose pathogens to toxic levels of zinc or reactive oxygen/nitrogen species. We hypothesize these stresses
inactivates (p)ppGpp hydrolases, promoting alarmone accumulation and bacterial persistence. To investigate
how metal stress impacts alarmone degradation, we will use structural biology, biochemistry and bacterial
genetics to study these enzymes in vitro and in vivo. Additionally, we will explore the potential of hydrolases as
antibiotic targets. While most antibiotics target essential genes, (p)ppGpp hydrolases have been overlooked due
to the assumption that alarmone accumulation caused by inhibiting them would be pro-survival and bacteriostatic.
However, our previous work with a related alarmone, (p)ppApp, suggests that unchecked alarmone accumulation
without hydrolase activity can be lethal. We will assess the viability of a “synthetase+/hydrolase-” state for
(p)ppGpp in Gram-negative pathogens to evaluate the therapeutic potential of hydrolase inhibition. Our research
will significantly expand the understanding of bacterial persistence and provide new insights into how bacteria
sense metal stress via alarmone signaling. The knowledge gained from this work could open new avenues for
therapeutic developments by targeting alarmone hydrolases. Our long-term vision is to identify bacterial
vulnerabilities that can be exploited to combat antibiotic persistence, improving clinical outcomes in the treatment
of chronic infections. This research is poised to make foundational insights to bacterial stress response and
resilience and advance our understanding of the communication between human hosts and bacterial symbionts.

Public health relevance
Project Narrative This research aims at advancing our knowledge on how bacteria respond to stress through a molecule called (p)ppGpp, which helps bacteria tolerate antibiotics and survive in harsh conditions by stopping their growth. We will study enzymes that degrade (p)ppGpp, focusing on how they catalyze (p)ppGpp degradation and how metal stress from human hosts inhibits their activity. By exploring these processes, we aim to uncover new ways to fight persistent infections by targeting these enzymes, which could lead to new therapeutic approaches.